Microglial regulation of Progranulin levels

Genetic mutations in Granulin (GRN) that result in reduced levels of its encoded protein, progranulin (PGRN),
have been implicated in several distinct neurological disorders, depending on the degree of PGRN reduction.
More specifically, haploinsufficiency resulting from heterozygous GRN mutations has been identified to be
causal for a subset of patients with frontotemporal lobar degeneration (FTLD), an adult-­onset
neurodegenerative disease. Furthermore, homozygous loss-­of-­function GRN mutations result in neuronal
ceroid lipofuscinosis (NCL), and single nucleotide variants that decrease plasma and brain PGRN levels are
risk factors for Alzheimer’s Disease (AD). The clear association between reduced levels of PGRN and
neurological disorders highlights the importance of adequate PGRN dosage in normal nervous system
function. The overarching goal of this project is to better understand the precise cellular and molecular
mechanisms that are involved in the regulation of PGRN. In order to reach this goal, we began by identifying
factors that could potentially modulate phenotypes associated with PGRN haploinsufficiency. The preliminary
data presented in this application clearly show that Nemo-­like kinase (NLK), an evolutionarily conserved
serine/threonine kinase, is involved in the regulation of PGRN levels and can modulate phenotypes associated
with PGRN reduction in vivo through microglia. To investigate this idea further, we propose the following three
specific aims. In Specific Aim 1, we will determine whether altering Nlk levels specifically in microglia can
modulate FTLD-­related phenotypes in vivo using mouse genetics. Specifically, (1) we will first test whether
constitutive loss of Nlk in microglia is able to induce FTLD-­related neuropathological and behavioral
phenotypes. (2) Conversely, we will examine if constitutive overexpression of Nlk in microglia can prevent or
ameliorate these same phenotypes. We will focus on neuropathological changes and behavioral deficits that
have been previously ascribed to PGRN reduction in FTLD-­PGRN patients and Grn knockout mice. In Specific
Aim 2, we will elucidate the molecular mechanism through which Nlk regulates Pgrn levels in microglia. We will
(1) employ mouse genetics and isogenic human induced pluripotent stem cell-­derived microglia to determine
the receptor involved in Nlk-­mediated regulation of Pgrn endocytosis and (2) utilize unbiased proteomics
approaches to identify direct molecular targets of Nlk that function in this regulation. In Specific Aim 3, we will
determine whether GRN-­associated neuropathology can be suppressed or reversed by increasing Nlk
expression in adulthood. To do this, we will temporally induce the overexpression of Nlk after disease onset
and test the efficacy in ameliorating or reversing pathological and behavioral deficits. We believe that the
knowledge gained from the studies proposed in this application will advance our basic understanding of the
cellular and mechanism underlying PGRN regulation and will suggest new therapeutic interventions aimed at
reducing the burden of FTLD and other neurological disorders associated with PGRN reduction such as AD.

Public health relevance
The burden of Alzheimer’s disease (AD) and Alzheimer’s Disease- Related Dementias (ADRD) is enormous, yet no effective therapeutics exist for a majority of disease symptoms. The studies outlined in this proposal will allow us to determine the cellular and molecular mechanisms underlying microglial regulation of Progranulin levels and associated neuropathological phenotypes, and therefore may lead to the development of improved treatments for neurodegenerative diseases resulting from Progranulin reduction in the future.